High-throughput DNT testing with engineered brain organoids

Project Summary/Abstract
Despite the potential vulnerability of developing brains to environmental toxicants, only a few hundred
compounds, among tens of thousands of commercially used chemicals, have been tested for
developmental neurotoxicity (DNT) due to the limitations of current US EPA and OECD guidelines for
DNT assessment which rely entirely on animal tests. Therefore, there is a critical need for predictive
cellular models for the assessment of DNT to rapidly prioritize potential environmental toxicants. To
address this unmet need, Bioprinting Laboratories Inc. (BPL) proposes to establish genetically
engineered, induced pluripotent stem cells (iPSCs) with a promoter-reporter assay system on a high-
throughput, pillar/perfusion plate platform and differentiate them into brain organoids to mimic the
complexity of brain development and accurately predict DNT potential by chemical exposure. Our
pillar/perfusion plate platform consisting of a 144-pillar plate with sidewalls and slits (144PillarPlate) and
a complementary 144-perfusion well plate with reservoirs and microchannels (144PerfusionPlate) can
combine unique features of 3D bioprinting and microfluidic perfusion culture of organoids, while
supporting high throughput and user-friendliness. In particular, the pillar/perfusion plate platform built on
the footprint of standard 384-well plates is compatible with existing high-throughput screening (HTS)
equipment such as automated fluorescent microscopes and microtiter well plate readers, which is an
important feature for organoid-based compound screening. Unlike traditional microfluidic devices, the
pillar plate with brain organoids can be easily detached from the perfusion plate and sandwiched onto a
384-well plate containing cell-staining reagents for high-throughput DNT assays.
Our core hypotheses are: (i) iPSCs with a promoter-reporter assay system can be differentiated into
engineered brain organoids to rapidly assess the expression levels of neural cell types, including neurons,
astrocytes, and oligodendrocytes; (2) the pillar/perfusion plate can facilitate robust dynamic culture of
brain organoids by eliminating the necrotic core of organoids and enable high-throughput, high-content
cell function analysis.
The specific aims of the proposed research are to: (1) generate human iPSCs with integrated
promoter-reporter assay systems for rapid assessment of brain organoid differentiation; (2) generate
engineered brain organoids with the promoter-reporter assay system in the pillar/perfusion plate and
evaluate DNT potential of various compounds.
We envision that engineered brain organoids with the promoter-reporter assay system in the
pillar/perfusion plate could be used for predictive screening of environmental chemicals, which in turn
can impact human toxicology, and ultimately, safer chemical product development and use.

Public health relevance
Project Narrative Bioprinting Laboratories Inc. aims to utilize its proprietary pillar/perfusion plates to differentiate genetically engineered, induced pluripotent stem cells (iPSCs) with a promoter-reporter assay system into brain organoids in the presence and absence of toxic chemicals. This approach allows for the assessment of the expression levels of neural cell types in brain organoids in a high throughput manner and simulates developmental neurotoxicity (DNT) resulting from chemical exposure. Thus, the engineered iPSCs and brain organoids may serve as tools for prioritizing the safety and usage of industrial and environmental chemicals.